Computational and neurodevelopmental mechanisms of memory-guided decision-making

PROJECT SUMMARY
Adolescence is accompanied by enhanced risk for maladaptive decision-making, a profile that confers risk for
psychopathology. Prior work has shown that memory and decision-making systems continue to mature during
adolescence, however, developmental studies have traditionally tested these cognitive processes in isolation.
As a result, remarkably little is known about how the development of memory and the corresponding neural
processes influence adaptive and maladaptive behaviors in youth. The proposed project will test a novel
conceptual model that specifies the neurodevelopmental pathways through which memory guides decision-
making during adolescence. This unifying framework formalizes the neurocomputational mechanisms underlying
two dimensions of memory-guided decision making: specificity and generalization. The proposed research will
test this conceptual model by leveraging recent advances from computational neuroscience, including artificial
neural networks, multivariate neuroimaging methods, and machine learning approaches to predictive modeling.
Aim 1 (K99 phase) tests the hypothesis that enhanced interactions between the hippocampus and striatum
support the use of memory specificity to guide decisions. Aim 2 (K99 phase) tests the hypothesis that enhanced
interactions between the hippocampus and vmPFC support the use of memory generalization to guide decisions.
Aim 3 (R00 phase) tests the overarching hypothesis that adolescents rely on specificity to guide decision-making
due to the early maturation of hippocampal-striatal circuitry, whereas generalization emerges during the
transition to adulthood, in tandem with strengthening connections between the hippocampus and ventromedial
prefrontal cortex (vmPFC). Further, Aim 3 will test the hypothesis that decreased hippocampal-striatal
interactions predict risk for depressive symptoms during adolescence. This work directly builds on the
candidate’s earlier postdoctoral work that has characterized the behavioral trajectories of memory-guided
decision-making during adolescence. By examining the computational foundations and neurodevelopmental
trajectories of memory-guided decision-making, the proposed research will reveal how learning and decision-
making processes refine with age during adolescence. This work has the potential to illuminate why adolescence
is a period of heightened risk for maladaptive decision-making, and the proposed research will identify how
aberrant decision-making confers risk for depression. This award will provide the candidate, who has a strong
background in developmental cognitive neuroscience, with critical training in computational modeling with neural
networks, multivariate fMRI methods, machine learning, and advanced statistical techniques to promote a
successful transition to an independent research career. The proposed research study and training plan will help
the candidate achieve her ultimate goal of leading an independent research lab, where she will implement
computational and translational approaches to study the neurodevelopment of adaptive and maladaptive
behaviors during adolescence.

Public health relevance
Project Narrative This work aims to characterize how adolescent brain development supports the maturation of memory-guided decision-making. Adolescence is a period of the lifespan accompanied by heightened risk for maladaptive decision-making, a profile that confers risk for psychopathology, including depression. By identifying how neurodevelopment shapes the ability to use positive memories to guide adaptive decision-making, these findings could have direct implications for understanding why adolescents are at increased risk for depression.